HYPERTENSIVE TREATMENT AND EPIDEMIOLOGICAL ANALYSES

With the use of antihypertensive medication increasing steadily over the last 25 years, treatment for hypertension in now common. Given the high prevalence of treatment for hypertension, researchers can no longer assume that participants in epidemiologic studies represent natural blood pressure measures, as opposed to treated blood pressure measures. The effect of this high prevalence of treatment, however, has not been fully investigated. Although it might seem that studies of "natural history" are no longer relevant, great interest currently exists in establishing both environmental and genetic determinants of blood pressure. Additionally, there currently is a renewed interest in refining treatment guidelines. For example, the need to account for absolute as well as relative risk has been hotly debated in recent years. The need will continue to exist, therefore, to analyze observational data sets to meet the evolving interest in the determinants of blood pressure and to meet the requirements for more refined risk estimates. Data analysts will be required to account for blood pressure treatment in their analyses of these data. To investigate the effect of blood pressure treatment on the analysis of epidemiologic studies, we will conduct two interrelated analyses using simulation studies and data from five observational studies: The Framingham Heart Study; the NHANES I, II, and III cohorts; and The International Collaborative Study of Hypertension in Blacks (ICSHIB). We will first conduct simulation studies to examine the behavior of different methodologies in each of two common analytic settings: relating body mass index to level of systolic blood pressure and relating level of systolic blood pressure to Coronary Heart Disease Mortality. We will use the data from our five studies to derive the parameters for use in our simulation studies. In these studies we will quantify the level of bias that results from ignoring the presence of blood pressure treatment in observational data. After conducting our simulations studies, we will repeat the analysis of the relationship between BMI and SBP using available empirical data.